Defining the genomic and biologic impact of LINE-1 activity in fallopian tube epithelial cells

High-grade serous ovarian cancer (HGSOC) is the deadliest gynecologic cancer in the United States.
Unfortunately, we have a limited understanding of the mechanisms contributing to the genesis of pre-cancerous
lesions identified as serous tubal intraepithelial carcinoma (STIC) of the fallopian tube, and their transition to
HGSOC. Ovulation occurring over a woman’s reproductive lifespan may contribute to the malignant
transformation by exposing the FT fimbria to follicular fluid (FF), which contains factors promoting follicle
rupture, inflammation, and tissue remodeling. Long INterspersed Element-1 (LINE-1, L1) is an endogenous
mutagen. The only active protein-coding human transposon, L1 mobilizes by a “copy and paste” mechanism that
creates a new copy in a new genomic location. L1 is repressed in normal somatic tissue by multiple mechanisms,
including DNA methylation and the p53 tumor suppressor. We and others have revealed that L1 expression and
new L1 genomic insertions are hallmarks of cancer. Ovarian cancers have some of the highest levels of L1 protein
expression, and we now detect L1 ORF1 protein (ORF1p) in plasma from these cancer patients but not healthy
females. Insertional mutagenesis by L1 can cause malignancies in humans by disrupting tumor suppressor genes,
and our data in in vitro experimental models show L1 causes chromosomal instability (CIN). However, whether
L1 contributes to ovarian tubal carcinogenesis is unknown. Supporting a potential causal role, DNA
hypomethylation has been implicated as one of the early events in tumorigenesis and promotes L1 activity. ORF1p
expression is induced in STIC lesions. STICs are concurrent with the histologic transformation of these cells and
their development of CIN. This raises the intriguing possibility that L1 activity represents an important contributor
to CIN in the pathogenesis of HGSOC. Based on our recent findings and accumulating evidence, we hypothesize
that ovarian FF and promote L1 expression in fallopian tube epithelial cells (FTE), leading to DNA damage and
genetic instability. We propose the following aims to test our hypothesis: 1: that FF promotes L1 expression in
the FTE ; and 2: expression of L1 in FTE contributes to genetic instability independently or in concert with
other known FTE premalignant genetic alterations, promoting a hyperplastic and eventually neoplastic
phenotype. Our proposed aims will utilize patient samples to ensure applicability, well-established as well as
novel assays and state-of-the-art technologies to test whether by itself or in concert with known genetic alterations
L1 promotes sufficient DNA damage and genetic instability to facilitate tumorigenesis in our in vitro and in vivo
preclinical models.Understanding the genomic impact of L1 in FTE and its potential contributions to malignant
transformation will allow for the development of novel strategies to target or prevent ovarian cancer.

Public health relevance
Using primary pre-clinical models, our overall objective is to we delineate how follicular fluid (FF) influences Long INterspersed Element-1 (L1) genomic and transcriptomic activity in ovarian tubal epithelial cells. In addition, we will assess whether the L1 activity, along with along with the FF induced inflammatory response along with other putative drivers can contribute to the genesis of ovarian cancer precursor lesions and their subsequent transformation.